Redefining Nanomedicine Beyond One-Size-Fits-All: Uncovering Mechanisms of Sex Differences and Female Life Stages in Drug Delivery

Project Summary
Historically, women's health has been significantly under-researched and underfunded, contributing to a
profound health gap that equates to 75 million years of life lost globally. Nanomedicine presents a promising
solution to addressing this gap, with its ability to precisely target tissues, bypass biological barriers, and control
therapeutic release while minimizing toxicity. However, like much of medicine, nanomedicine design has been
approached through a one-size-fits-all lens, failing to address variations in biology and nanoparticle (NP) efficacy
across diverse patient populations. This absence of tailored design likely contributes to the limited clinical
translation of nanomedicines, despite its potential to revolutionize medicine. The proposed research seeks to
address critical gaps in our understanding of sex and female life stages in nanomedicine delivery. While previous
research has shown that NPs function differently in males and females, the underlying mechanisms are not well
understood. Key Question 1 aims to uncover these mechanisms and identify the key factors that impact NP
delivery and efficacy by systematically evaluating NP performance across cellular (NP uptake),
microenvironmental (protein corona and mucus transport), and systemic (circulation, stability, immune response,
biodistribution) levels. For each of these levels, mechanisms driving sex-dependent differences will be
investigated. Additionally, this research will go beyond treating sex as binary, considering it as a spectrum that
intersects with age and hormone levels in the female body, marking one of the first studies to examine how
menstrual cycle phase, hysterectomy, and menopause affect NP protein corona formation, transport, and
biodistribution. Importantly, our work will utilize a library of clinically relevant lipid- and polymer-based NPs with
precisely controlled size and charge properties, addressing a key gap in limited studies that have explored sex
differences in NP delivery but overlooked the importance of these tailored NP characteristics.
Moreover, vaginal delivery, which offers transformative potential for localized and systemic treatment, remains
underexplored in nanomedicine despite its advantages for women-specific diseases. Key Question 2 will
investigate the use of thermo- and enzyme-responsive hydrogels to optimize vaginal NP delivery systems,
enhancing precise and effective drug targeting. Vaginal delivery has primarily been evaluated in the context of
sexual and reproductive health conditions, but its broader applications, particularly with clinically relevant NPs,
remain largely unexplored. This research will compare vaginal delivery of NPs with traditional administration
routes such as intraperitoneal and intravenous delivery, seeking to uncover its potential for targeting both
reproductive and non-reproductive organs. Ultimately, this research aims to shift drug delivery from one-size-fits-
all therapies to personalized nanomedicines that address the diverse needs of patient populations, ultimately
advancing more equitable healthcare outcomes.

Public health relevance
Project Narrative This research investigates mechanisms driving sex differences in nanoparticle delivery systems and seeks to optimize systems for vaginal delivery of therapeutics. By examining how biological variables such as sex and menstrual cycle phase impact nanoparticle interactions and drug delivery efficacy, this project aims to uncover mechanisms that can be leveraged to create more personalized therapies. The findings will inform the development of tailored nanomedicines for a range of diseases, promoting equitable healthcare solutions that move beyond one-size-fits-all therapies.